A Unique, Co-Designed Family-Based Therapy for Marginalized Women with Opioid Use Disorder and Justice-Involvement

Project Summary/Abstract
Aaron Murnan, PhD, LMFT is a tenure-track assistant professor at University of Cincinnati's College of
Nursing. His career goal is to become an independent clinician-scientist with expertise in co-designing novel
interventions to address salient treatment needs among families disproportionately impacted by opioid use and
justice-involvement, specifically women in the sex trade. The term `co-design' refers to a community-based
participatory research methodology in which individuals with lived experience are engaged as study team
members to lend their hands-on expertise and thoroughly participate in the intervention development process.
Given well-documented risks associated with the sex trade and opioid use, as well as a lack of interventions
prospectively designed to address challenges experienced by this population, the current study represents a
critical next step towards promoting the health and well-being of women in the sex trade. The proposed five-
year Mentored Patient-Oriented Research Career Development Award (K23) will provide Dr. Murnan a perfect
opportunity to achieve his career goals through training in: 1) Community-Based Participatory Research; 2)
ADAPT-ITT substance use intervention adaptation methodologies; and 3) conducting research within the
criminal justice system. Dr. Murnan's proposed study aims to evaluate the feasibility and acceptability of co-
designed family-based intervention offered as an adjunct to treatment diversion programming (offered through
the criminal justice system) using a pilot RCT design. In Aim 1, participant family dyads (n=15 women paired
with one supportive family member) will be recruited to explore intervention needs, motivations, and barriers
related to participating in family-based intervention, as well as delivery preferences. This information will be
used by the co-design team (individuals with lived experience, the PI, and other research personnel) to adapt a
family-based intervention manual. For Aim 2, additional family dyads (n=60) will be recruited to participate in a
randomized controlled trial in which they will be randomly assigned to one of two treatment arms: 1) co-
designed family-based intervention + diversion treatment programming or 2) diversion treatment programming
only. Feasibility, acceptability, and preliminary efficacy of both interventions will be evaluated (Aim 2). Dr.
Melinda Butsch Kovacic, a leading expert in community-based participatory research, will serve as Dr.
Murnan's primary site mentor. Dr. Butsch Kovacic in conjunction with his co-mentors (Drs. Jennifer Brown and
Sarah Manchak) will provide him with necessary training in areas of community-based participatory research,
substance use intervention adaptation methodologies, and conducting research within the criminal justice
system, that will launch his independent research career as a clinician scientist with the requisite skills to
conduct high quality intervention research to promote best outcomes among families disproportionately
impacted by opioid use and criminal justice involvement.

Public health relevance
Project Narrative This research is relevant to public health as it seeks to co-design a family-based intervention to better address the opioid use treatment needs of a uniquely marginalized population of women affected by opioid use and criminal justice involvement. Effective intervention strategies for these women and their families are non- existent; therefore, the current study addresses this gap by adapting and pilot testing a family-based intervention, co-designed with members of these families to address their unique needs. This work is closely aligned with NIDA's strategic plan to fund research to improve opioid use treatment approaches implemented within criminal justice systems that support meaningful and sustained recovery among vulnerable and marginalized populations.